Structure and function of Helicobacter pylori VacA

PROJECT SUMMARY (ABSTRACT)
Helicobacter pylori is a Gram-negative bacterium that colonizes the gastric mucosa of humans. Although most
H. pylori-infected persons remain asymptomatic, potentially serious sequelae of infection include gastric
adenocarcinoma, duodenal or gastric ulceration, and gastric lymphoma. Gastric cancer is the third leading
cause of cancer-related death worldwide, and H. pylori has been classified as a type I carcinogen by the World
Health Organization. One of the major secreted proteins of H. pylori is a toxin known as VacA. There is a high
level of genetic variation among vacA alleles from unrelated H. pylori strains, and the encoded VacA proteins
exhibit marked differences in their ability to cause alterations in human cells. A large body of literature indicates
that H. pylori strains containing certain forms of vacA (termed s1, i1, or m1) are associated with a higher risk of
gastric cancer or peptic ulcer disease than are strains containing other forms of vacA (termed s2, i2, or m2).
Thus, VacA is considered to be an important H. pylori virulence factor. Most cellular effects of VacA are
dependent on its ability to oligomerize and form anion-selective membrane channels, but relatively little is
known about the molecular basis for these two critical steps in the VacA mechanism of action, and almost
nothing is known about the roles of VacA oligomerization and pore formation in vivo. Therefore, the specific
aims are to (i) elucidate the process by which VacA assembles into oligomeric structures; (ii) elucidate the
process by which VacA inserts into membranes to form anion-selective channels, and (iii) define the
consequences of VacA oligomerization and membrane channel formation in animal models. This work is
relevant not only for the study of H. pylori-associated diseases, but will also increase our understanding of
bacterial pore-forming toxins, chloride-conducting membrane channels, and β-helical passenger domains
secreted by an autotransporter pathway.

Public health relevance
Project narrative (Relevance to Public Health) A bacterium known as Helicobacter pylori colonizes the stomach in about half of all humans; most do not develop any symptoms related to this infection, but some develop stomach cancer or peptic ulcer disease. Stomach cancer is the third leading cause of cancer-related death worldwide and H. pylori infection is the leading cause of stomach cancer. The long-term goals of this research are to understand the molecular mechanisms by which H. pylori infection can lead to disease, and to understand the basis for variation in clinical outcomes among H. pylori- infected persons.